Telomere dysfunction driven molecular outputs in the cardiac unit

PROJECT SUMMARY
Our R01 project will examine the molecular mechanisms underlying environmental exposure-induced telomere
damage on mitochondrial function and cellular senescence in cardiac disease. Environmental insults have long
been associated with oxidative telomere damage and heart disease. This project seeks to move the field beyond
an association and determine the causative role of telomere damage in promoting early onset of age-related
cardiac dysfunction. Traditionally, telomere shortening has been studied to explain proliferative exhaustion.
However, this is inadequate to explain aging and disease of a largely post-mitotic tissue, such as the heart.
Telomere associated foci (TAFs) or DDR+ telomere foci have been reported in multiple cell types of the heart,
including cardiomyocytes (CMs) and cardiac fibroblasts (CFs). Our preliminary data shows that telomere-driven
senescence is linked to oxidative stress but not telomere shortening, suggesting that oxidative damage
contributes to the DDR+ of telomeres and senescence observed in cardiac tissue. A prior lack of tools to induce
oxidative damage in a spatial and temporal manner severely limited the ability to understand how such telomere
damage contributes to cardiac disease. Now, we have developed an innovative chemoptogenetic tool that
produces oxidative damage, 8-oxoguanine (8-oxoG) lesions, specifically at telomeres, thus mimicking
environmentally induced telomere damage. Another critical barrier in understanding the cell autonomous versus
non-autonomous role of telomere damage in a complex tissue like the heart was the lack of a platform to
introduce telomere damage in one cell type (e.g., CM) and examine its effect on another (e.g., CF), and on
cardiac function. We have now also developed tools that enable the study of cell-cell communication in a 3D
multicellular system, allowing us to reproduce tissue dynamics present in the heart. We will test the hypothesis
that oxidative damage at telomeres in specific cardiac cell types leads to mitochondrial dysfunction, senescence,
and release of paracrine factors, thus contributing to electrophysiological changes and heart disease. We will
induce oxidative telomere damage specifically in induced pluripotent stem cell (iPSC)-derived CMs and CFs to
explore three aims: (1) map how oxidative telomere damage communicates with mitochondria to drive a
biological outcome- senescence; (2) define the cell non-autonomous role of telomere damage in the heart; and
(3) examine the molecular role of repair at telomeres in cardiac health. Our team is uniquely qualified to perform
this work, with expertise in telomere damage/repair, mitochondrial assessments, cellular senescence,
nanofabrication, and human iPSC-derived cardiac tissue engineering. This project is highly significant because
it will allow us to gain a more comprehensive understanding of the role of environmental driven telomere status
on cardiac health, which will lead to the discovery of promising new therapeutic targets.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health given that environmental insults and oxidative stress drive telomere damage and promote cardiac dysfunction. Here, we will investigate how oxidative damage at telomeres affects mitochondria and metabolism to drive cellular senescence. Deciphering the molecular interactions governing telomere status in response to environmental insults is expected to uncover therapeutic targets that could prevent the progression of cardiac diseases.